SECRETIONS OF ARTHROPODS

DESCRIPTION (Adapted from the Applicant's Abstract): The study deals with the chemical mechanisms by which insects interact with organisms in their environment. It is aimed at elucidating the chemical structure and biological function of substances that insects use for defense against enemies, communication with mates, and protection of offspring. Molecular characterization will be effected by modern analytical techniques (GC and HPLC; mass and nuclear magnetic spectrometry); biological studies will involve field and laboratory bioassays, structural and ultrastructural studies of glands, and various techniques for elucidation of physiological functions.